University of Louisville Cagewash Modernization

ABSTRACT
The University of Louisville (UofL) is an Institution of Emerging Excellence (IEE) and one of 23
states designated by the National Institutes of Health (NIH) as an Institutional Development
Award (IDeA) state, serving the research needs of medically underserved communities. As part
of the IDeA state program, UofL is the recipient of four NIH funded Centers of Biomedical
Research Excellence (COBRE) projects to target local and regional health crises in Kentucky
and Appalachia. These include centers in 1) Center for Cardiometabolic Science, 2)
Microbiomics and Inflammation, 3) Hepatobiology and Toxicology, and 4) Cancer Immunology
and Immunotherapy. UofL is also the recipient of NIH funding for the Alcohol Center and the
Envirome Institute Superfund Research Center, which studies the effects of cigarette smoke, e-
cigarettes and other inhaled toxins on the cardiovascular system. UofL is requesting
$306,360.00 for a modern, innovative, eco-friendly tunnel washer in the centrally located A-
Tower Research Building Cagewash Facility. The A-Tower is adjacent to six research buildings
that comprise the nucleus of the Health Sciences Campus (HSC), and serves as the primary
cage wash facility for all rodent species on the HSC and the undergraduate Belknap campus. It
also provides essential support for large animal cage washing. The current tunnel washer is
over 20 years old, and is not ergonomically or eco-friendly. Routine maintenance and repair are
frequent and costly. The Better Built Tunnel Washer, Model T236, represents a major innovative
upgrade in cage wash equipment that is eco-friendly, integrative, and utilizes microcomputer
technology. The new tunnel washer will increase our current cage wash throughput capacity by
25% for rodent caging and large animal caging accessories, to accommodate our growing
rodent and large animal populations. The new cage washer will provide essential support for the
four NIH funded COBRE grants, the Envirome Institute Superfund, and 64 investigators in 24
departments across the HSC and Belknap campus. A broad, diverse range of investigators and
their research efforts in both biomedical and basic sciences will benefit from this equipment in
this shared-use facility. This aligns with the principal missions of the NIH-NIGMS. UofL echoes
these missions, with the establishment of the Diversity, Equity and Inclusion Strategic Plan in
2017 and the HSC Office of Diversity and Inclusion, which is committed to expanding funding
and employment of ethnic minorities.

Public health relevance
Narrative The University of Louisville (UofL), an Institution of Emerging Excellence (IEE) located in an Institutional Development Award (IDeA) program state, requests funds ($306,360.00) to modernize our shared-use A-Tower Cagewash Facility, which provides primary support for rodent and large animal facilities utilized by NIH funded investigators from seven departments on the Health Sciences Campus. The first phase in modernizing this facility is to replace the current Scientek tunnel washer (installed in 1999) with a modern, eco-friendly, integrative tunnel washer that will also improve ergonomics and reduce allergen exposure for our staff. Our current tunnel washer is dated, energy inefficient and unable to meet our current cage washing demands as our animal census increases in our existing facilities, and will balloon once our A- Tower vivarium construction project is complete in 2023, which will add 2,112 rodent cages.